Rumbo: An Integrated Mobile and Web-Based Application to Overcome Barriers to Receive Substance Use Disorder (SUD) Treatment and Improve Outcomes for Spanish-Speaking, Hispanic and Latinx Individuals

PROJECT SUMMARY/ABSTRACT
Substance use is a significant problem among Latinx and Hispanics due to the
disproportionate number of physical harms and negative consequences associated with
substance use relative to other racial/ethnic groups. However, Hispanics are less likely
than other racial/ethnic groups to seek treatment for substance use, regardless of the
substance(s) they use, and only 75% as likely to complete treatment for heroin as White
individuals. Treatment navigators, like patient portals, were originally intended to offset
disparities in access to treatment and health care. Unfortunately, initial uptake of these
patient-facing eHealth tools was found among white, educated, middle-class individuals
already actively engaged in their own health care and not by socially disadvantaged and
marginalized minority populations, as though the structural barriers to care that exist in
the treatment system were carried forward in the solution meant to overcome them.
Nonetheless, there are still many who believe that eHealth has the potential to help
marginalized people seeking care to surmount these barriers. Research over the last
decade has revealed that adoption of eHealth among marginalized populations is
influenced by factors such as health information-seeking behaviors, level of eHealth
literacy, and technology acceptance, so we have designed a treatment navigator for
Hispanics that is informed by these findings. “Rumbo” is an easily shared bi-lingual
integrated web and mobile application that helps both Spanish-speaking and non-Spanish-
speaking Hispanic individuals with substance use challenges find and access treatment
services and related supportive resources. The proposed innovation stands out from other
eHealth tools by leveraging the collective efficacy of the Hispanic community to overcome
barriers and support individuals’ self-efficacy for engaging the treatment system. Rumbo’s
simple, user-centered design provides less-acculturated Hispanic individuals with a
culturally appropriate tool to understand their needs within the complex US treatment
system. In this Phase I project we will develop the app’s content and functions with a
community-based, user-centered, iterative design process that will inform the content and
functions of the app. We will gather key stakeholders in the Bernalillo County treatment
system (the most populous area in New Mexico and 50% Hispanic) to develop a database of
available, culturally appropriate resources, and to support both project recruitment and
dissemination of the initial version of the app. Once completed, we will evaluate Rumbo’s
acceptability and capability as a treatment navigator in a naturalistic implementation
study, as well as how it is shared among users, and whether the individuals who use
Rumbo subsequently have increased confidence in accessing services.

Public health relevance
PROJECT NARRATIVE Hispanic and Latinx individuals in the United States experience disproportionate levels of physical harms and negative consequences associated with substance use relative to other racial ethnic groups. Yet Hispanics are less likely than other racial/ethnic groups to seek treatment for substance use, and also less likely to complete treatment. The purpose of this project is to develop an easily shared mobile application that helps Spanish-speaking and less-acculturated Hispanics with substance use challenges find and access culturally appropriate treatment services and related resources. If successful, the proposed innovation will significantly enhance access to drug treatment resources for millions of individuals who currently live outside the U.S. healthcare system.